Gene regulatory network plasticity in social behavior

Environmental and developmental variation play large roles in shaping phenotypes, yet our
understanding of how phenotypic plasticity evolves and is mediated through gene regulatory networks (GRNs)
is limited. This knowledge gap hinders our ability to predict how novel or changing environments will affect
phenotypes, as well as the evolutionary consequences of these changes. To better understand how both
adaptive and aberrant phenotypes emerge from GRN architecture, we need tractable models which vary in a
phenotype of interest. The proposed research takes an integrative approach to address the gene regulatory
mechanisms underlying social behavior in a group of bees with extensive variation in sociality within and between
species. This natural variation enables us to study the mechanistic basis of plasticity across both developmental
and evolutionary timescales. My proposed research combines functional genomics with computational biology
and behavioral profiling to identify gene regulatory plasticity and the consequences of this plasticity in the
evolution and development of social traits. I approach these questions from multiple angles, optimizing risk and
reward and providing training opportunities for students and postdocs in genomics, computational biology, and
behavior. Objectives of the proposal include: 1) identifying GRN changes associated with evolutionary gains and
losses of social behavior, 2) molecular profiling of developmental stages and behavioral phenotypes to determine
how GRNs generate intraspecific plasticity, and 3) experimental manipulation of common trans-regulatory
environments and use of massively parallel reporter assays to identify context-dependent gene regulatory activity
across species. Together, outcomes of these studied objectives would provide fundamental insights into how
GRN architecture is modified and utilized during the evolution and development of social traits. More generally,
this work will expand our understanding of how phenotypic plasticity emerges from changes in gene regulation,
an underappreciated contributor to the evolution of novel phenotypes.

Public health relevance
The overall objective of the proposed work is to uncover rewiring of gene regulatory networks (GRNs) during evolutionary transitions in sociality. By identifying these rewiring events and their associated consequences on the development of social phenotypes, we will provide fundamental insights into how GRN architecture is modified to facilitate the evolution of novel traits. This work fills a critical knowledge gap in our understanding of the interplay between GRNs, environmentally-induced plasticity, and the development of phenotypes in an emerging model system of social behavior.